INnovative data Science to Impact the TB Epidemic - INSITE

PROJECT SUMMARY
There are limited opportunities in Africa to work with routine clinical and health data at scale, and to develop the
expertise to process these data in an environment in which both the burden of disease and the approach to
enumeration and coding are very different to other settings where routine data are exploited for epidemiological
analyses. Tuberculosis disease (TB) is the most important HIV-associated comorbidity in South Africa and the
leading cause of death in people living with HIV (PLH). Maternal TB (pregnancy and postpartum period)
deleteriously affects morbidity and mortality in women and infants. Pregnancy outcomes are worse, exacerbated
by HIV co-infection which is present in 60%, and there is increased risk of perinatal TB and HIV transmission.
Rifampicin-resistant (RR)-TB with/without fluoroquinolone resistance is a growing global public health concern
with prevalence rates at 4.2% of TB cases in the Western Cape Province, South Africa. South Africa was prompt
to include novel and repurposed second-line therapeutic agents against RR-TB in routine guidelines, including
pregnant and lactating people. The safety of these agents during pregnancy and lactation is uncertain but the
rising incidence of RR-TB has seen the use of these agents during pregnancy at scale. The concomitant use of
antiretroviral therapy (ART) for HIV treatment raises concerns about potential drug-drug interactions with safety
and efficacy implications. Maternal TB remains under-prioritized globally despite the burden of HIV and TB in
those of child-bearing age.
In this context of high infectious burden in which novel/repurposed anti-mycobacterial agents for the prevention
and treatment of TB are used at scale during pregnancy, often co-administered with ART, the Western Cape is
uniquely positioned in hosting the Provincial Health Data Centre (PHDC), the first comprehensive linked health
information exchange in Africa. The PHDC leverages the use of a province-wide unique patient identifier issued
to users of the health services to harmonise all electronic health data from routine health information systems in
public sector facilities, including laboratory, pharmacy, administrative and other clinical data. These data are
integrated and curated to enable inference of health conditions using phenotype algorithms, as well as to enable
the consolidation of co-morbidities and construction of patient-level cascades that can be used to monitor and
analyse health service utilisation patterns and healthcare outcomes.
The partnership between the Centre for Infectious Disease Epidemiology & Research, University of Cape Town
and the Health Intelligence Directorate of the Western Cape Government which houses the PHDC offers a
unique opportunity to develop and evaluate a robust maternal TB data platform, using data science to i) create
actionable clinical tools to optimize person-level interventions and monitor programs; ii) generate large, linked
cohorts to address the epidemiological questions of maternal TB and assess the impact of policy interventions
and clinical tools at the population and individual levels.

Public health relevance
PROJECT NARRATIVE New drugs and shortened combination regimens have been introduced for the prevention and treatment drug- susceptible and drug-resistant tuberculosis (TB) but their impact on pregnant people and their infants, including TB transmission and pediatric TB, is uncertain. This partnership between the Centre for Infectious Disease Epidemiology & Research, University of Cape Town and the Western Cape Health Intelligence Directorate will consolidate existing relationships across clinical, epidemiological and data science disciplines to establish a scalable data infrastructure for the management of maternal TB at the regional and individual clinical levels. Data science techniques will be employed to develop and enhance a novel and robust public service population-level data harmonization platform to i) create actionable clinical tools to optimize person-level interventions and monitor programs; ii) generate large, linked cohorts to address epidemiological questions and assess the impact of policy interventions and clinical tools at the population and individual levels.